The Pediatric Injury and Violence Prevention Student Internship Training Program (INSIGHT)

ABSTRACT
Injury and violence are leading causes of pediaric death and disability, contribute to health inequities, and
minority groups are disproportionately affected. The Pediatric Injury and Violence Prevention Student Internship
Training (INSIGHT) course is an innovative, interdisciplinary, and intensive 8-week NICHD funded
(R25HD094336-04; Vavilala PI; 2018-2023) mentored research experience for upper-level undergraduate
students intended to increase the research workforce in pediatric injury and violence prevention. The focus on
pediatric injury and violence prevention is unique, and the program has exceeded goals set during the initial
award period. Since 2018, INSIGHT course applications increased four-fold, and INSIGHT has increased the
pediatric injury and violence prevention research pipeline, including the number of first generation, or otherwise
underrepresented students exposed to research education, health professions, and pediatric injury and violence
prevention. Specific Aims for the competing renewal (years 5-10) are: 1) To provide an immersive and rigorous
mentored research experience in pediatric injury and violence prevention, 2) To impart critical and tailored
professional development capacity building skills needed for successful pediatric research careers, and 3) To
increase recruitment and training of students from backgrounds underrepresented in research. INSIGHT trainees
will receive a rigorous research experience along with a curriculum of interactive seminars and scientific
presentations, and are taught skills intended to contextualize the research and to successfully compete for higher
educational opportunities and research careers. In this renewal application, we propose innovations in research
topics, research methods, and course programming. INSIGHT success takes many forms, from recruitment of a
highly diverse student population, to development of research products suitable for publication, and to the
growing number of program alumni who pursue careers with research, particularly in injury and violence.

Public health relevance
NARRATIVE The Pediatric Injury and Violence Prevention Student Internship Training Program (INSIGHT) is an intensive, eight-week interdisciplinary and rigorous research education course in pediatric injury and violence prevention for upper-level undergraduate students. Trainees are matched to research faculty experts in pediatric trauma and injury control, and all work involves a health equity lens. Research areas include elucidating risk factors and outcomes of pediatric injury and violence, community engaged research in injury and violence prevention, acute and chronic care of injured patients, trauma outcomes, and interventions to return the injured child and adolescent to full potential.